Specific Pathogen Free Baboon Research Resource (SPFBRR) - Bridge Funding Administrative Supplement

PROJECT SUMMARY
This application is a request for bridge funding for the “Specific Pathogen Free Baboon Research
Resource” (SPFBRR) P40 OD024628. The SPFBRR was founded with NIH support at the University of
Oklahoma Health Sciences Center (OUHSC) in 2002 and was relocated to the Keeling Center in 2017. The
SPFBRR has received continuous NIH support since it was founded. The SPFBRR is the only national
research resource of adventitious virus free olive baboons (Papio anubis) that are available to NIH grantees;
intramural research programs of federal agencies, including the FDA, NSF and NIH; and other sponsors of
biomedical research (private foundations, pharmaceutical companies, and contract research organizations).
Absolutely unique in the entire world, the baboons in the SPFBRR have an extensive bioexclusion list of 18
pathogens normally found in other wild and captive nonhuman primate colonies. The SPFBRR has
integrated multiple disciplines into a program designed to meet the needs of investigators who utilize its
resources. During the proposed period of support, the SPFBRR will continue to improve the resources it
provides to users and will continue to add new information about the biology and research value of virus free
baboons to its website. Baboons continue to be important animal model for genetically engineered pig
xenotransplantation, are the only NHP model of respiratory syncytial virus and whooping cough, and they
remain a very important model of bacterial sepsis. Additionally, baboons are excellent models of human
COVID associated pneumonia, and they were instrumental in the development of approved vaccines for
SARS CoV-2. Over the next year the SPFBRR will focus on maintaining the SPF18 baboon breeding colony
to meet current and future biomedical research needs. The overall goal of the SPFBRR is to provide a
national research resource of virus free olive baboons; provide baboon derived biological materials;
provide education and training opportunities to scientist, colony managers, and animal caregivers
who want to work with baboons; and to provide investigators with facilities and expertise to conduct
studies using virus free baboons.

Public health relevance
PROJECT NARRATIVE The “Specific Pathogen Free Baboon Research Resource” (SPFBRR) is the only national research resource of adventitious virus free olive baboons (Papio anubis), their tissues and other biological materials, as well as the expertise to carry out research on this invaluable research animal. Scientist with NIH grants utilize virus free baboons to study the immunobiology of pig to baboon xenotransplantation, ways to develop or improve vaccines for SARS CoV-2, respiratory syncytial virus and pertussis, and to study the development of Alzheimer’s disease and related dementias. Our goal is to provide support to maintain the SPFBRR and to continue to provide resources to the biomedical research community for the next year.